SERINE PROTEINASE INHIBITORS IN INSECTS

Serine proteinase inhibitors from the serpin superfamily in human blood plasma are important in regulation of blood clotting and complement activation, and they protect tissues from proteinases released by neutrophils during inflammation. Deficiencies or mutations of serpins in humans lead to several hereditary diseases. A complex serpin gene that can produce, through alternate exon splicing, a large number of serpin proteins has been isolated from an insect, the tobacco hornworm, Manduca sexta. The serpins from this insect are biochemically similar to human serpins, but their functions in insect biology remain to be elucidated. Insect serpins may regulate serine proteinases in the phenoloxidase activation cascade and may also regulate proteinases released by hemocytes in response to microorganisms. Many bloodsucking insects are important vectors of human diseases, and biochemical defenses such as the phenoloxidase activation cascade, and hemocyte cellular responses may be involved in the capacity of insect species to act as vectors. A long-term objective of this project is to apply knowledge and molecular probes obtained from this work with a model insect to study homologous molecules in insects that are vectors of human disease, but which are not so amenable to biochemical experiments. The specific aims of the project are: 1. Characterize the inhibitor selectivities of the serpin gene 1 products produced through alternate exon usage. Recombinant proteins will be expressed from serpin cDNAs, and the purified proteins will be tested for inhibitor activity against a panel of vertebrate serine proteinases to assess their selectivity. 2. Characterize serine proteinases from Manduca that are potential targets for regulation by hemolymph serpins. Serine proteinase cDNAs that have been isolated from a hemocyte library will be sequenced and compared with other known proteinases. The proteinases will be expressed as recombinant proteins and their enzymatic properties will be characterized. 3. Characterize the cDNA, gene, and protein product of a newly discovered Manduca serpin gene 2. The study of insect serpins may provide targets for novel methods of insect control and may yield valuable basic information as a non- vertebrate model for serpin biochemistry and molecular biology.